Liver-islet and intra-islet cross talk in alpha cell hyperplasia and beta cell regeneration

ABSTRACT
While evaluating the potential for glucagon receptor antagonists (GRAs) to maintain glucose homeostasis in
T1D rodents, we noted that GRAs promote β−cell survival and regeneration. Remarkably, GRA-treated mice
maintained normal blood glucose, even after the treatment was withdrawn. Our recently published data
suggest that: 1) ablation or antagonism of the glucagon receptor (GcgR) blunts apoptosis and stimulates
regeneration of functional β-cell mass in mice; 2) much of this new insulin+ mass derives from the conversion
of α−cell precursors into insulin-producing cells; and 3) GRAs restore sustainable euglycemia and insulin
production in diabetic NOD mice and in mice grafted with human islets. Our preliminary results suggest that the
β-cytotrophic effects of GRAs occur through both islet autonomous effects and through a well described liver-
α-cell axis4-7 which triggers α-cell hyperplasia through AA-dependent mechanisms (Figure 1). We have
identified Foxn3, a glucagon-responsive transcriptional repressor and novel mediator of glycemia8-11, as the
previously-undefined integrator by which glucagon alters amino acid metabolism. In parallel, we have
identified the GRA-driven upregulation of fibroblast growth factor 2 (FGF2), a target of the proliferative
transcriptional co-factor Yes-associated protein 1 (YAP1) that is expressed in Sox9+ ductal cells, as a key
contributor to GRA-mediated revival of a regenerative niche within the islet. We hypothesize that impaired
glucagon action promotes hepatic Foxn3-mediated α-cell hyperplasia via changes in amino acid metabolism
and an FGF2-mediated regenerative niche within the islet to allow α-cell to β-cell conversion in T1D. We will
evaluate our hypothesis using a cadre of novel, validated, and uniquely-suited mouse models which facilitate
our genetic dissection of the mechanisms linking the loss of glucagon signaling to altered hepatic utilization of
amino acids, α-cell hyperplasia, and the restoration of functional β-cell mass via two aims. 1) Using PANIC-
ATTAC diabetic mice, cultured murine islets, and cultured human islets, we will examine the islet-autonomous
effects of glucagon receptor antagonism or ablation on β-cell survival and β-cell regeneration. 2) We will
examine α-cell hyperplasia, β-cell survival and the regeneration of functional β−cell mass after liver-specific
deletion or overexpression of Foxn3.

Public health relevance
NARRATIVE Our recent works with drugs which oppose glucagon action demonstrate effective lowering of blood glucose in animal models of type 1 diabetes with an unexpected and profound increase in insulin-producing beta cells. As such, suppressing glucagon production or action on target tissues (which include the liver and the beta cell) may be a viable target area for the treatment and prevention of Type 1 diabetes. Here we evaluate the ability of glucagon blockade to improve beta cell regeneration, the source of new beta cells, and the tissue-to-tissue communication which triggers the regeneration of beta cells in mouse models of T1D and human islets.